Identification and analysis of chicken DLL3 as a segmentation clock component

Abstract
The Notch signaling pathway is a highly conserved cell:cell communication pathway that plays critical
roles in many aspects of metazoan development. Tight spatial and temporal regulation of this pathway is
crucial in many developmental decisions, and understanding the molecular mechanisms contributing to this
elegant control is an area of broad interest. The proposed research uses evolutionary changes in the
segmentation clock to explore modes of Notch pathway regulation that rely on cell-autonomous functions of
Notch ligands.
The segmentation clock comprises a network of oscillatory gene expression that functions in the
temporal regulation of somitogenesis. The mammalian clock requires expression of an atypical ligand called
DLL3 that can not activate Notch signaling, but is able to modulate the pathway in a cell autonomous way. We
have identified a chicken homolog of DLL3, and find that its predicted structure suggests that it too will be
unable to activate Notch signaling. This finding highlights the segmentation clock as a developmental process
that relies on cell autonomous ligand functions, providing a model to understand the novel mechanisms that
regulate the Notch pathway in cis. The mechanisms that underlie cis interactions between Notch ligands and
receptors, or between co-expressed ligands are poorly understood, and the segmentation clock provides an
outstanding model to dissect these interactions. Two aims will provide support for the central model that cell
autonomous ligand activities are critical for regulation of segmentation clock function. First, we will assess the
expression and function of the chicken DLL3 protein. RNA in situ hybridization will assess cDll3 expression
during chick embryogenesis and expression of tagged cDLL3 protein in cell culture will be used to identify the
subcellular localization of the protein. Functional assays will asses the ability of cDLL3 to interact with other
Notch pathway components, and how its expression affects Notch pathway activity. A second aim will directly
examine whether cDLL3 expression is required for segmentation clock function in developing chick embryos.
The work proposed here will provide critical data to support the central hypothesis that cell-autonomous
ligand activity provides a critical mechanism to regulate Notch pathway activity in the segmentation clock. We
anticipate that the results from this work will have broad implications for our understanding of how the Notch
pathway is regulated, allowing a pathway that appears straightforward on the surface to contribute to complex
developmental decisions across metazoans, and providing new insights into how pathway dysregulation can
contribute to congenital anomalies in human development.

Public health relevance
Project Narrative The Notch pathway acts in a variety of developmental contexts, including regulation of a genetic "clock" that times the segmentation of vertebrate embryos. When the functions of genes linked to this clock are perturbed, this can cause congenital defects including skeletal deformities such as scoliosis in humans. The research proposed here will use the evolutionary conservation of the clock to explore a novel mechanism that can control the clock function in a cell autonomous manner, providing information that will allow us to target treatments for defects and diseases that arise from dysregulation of the clock, and from perturbed Notch signaling in other contexts.